Human cutaneous responses to arthropod-mediated viral transmission

SUMMARY
Arthropod-borne viruses (ABV), such as Zika virus (ZIKV), Dengue virus (DENV) and tick-borne viruses (TBV)
are responsible for major health and economic concerns worldwide. ABV are transmitted to humans through the
bites of infected arthropods, mainly mosquitoes and ticks. Upon mosquito bite, mosquito saliva triggers specific
cutaneous immune responses that foster effective ABV transmission and systemic dissemination. However, our
understanding of how mosquito feeding remodels skin responses to favor ABV transmission has been
significantly hindered by the lack of animal models that accurately mimic human cutaneous responses to natural
ABV transmission, impeding the development of antiviral countermeasures against ABV.
While routinely used in infectious disease and immunology research because of their cost-effectiveness
and amenability to genetic manipulations, mice harbor significant immunological and cutaneous differences from
humans that hamper their use in uncovering mechanisms of ABV transmission. Indeed, the human and mouse
immune systems display critical functional differences, and the human and mouse skins are structurally distinct.
Mice reconstituted with a human immune system (HIS mice) have been shown to be permissive to ABV infection
and mount human-like immune responses to these viruses. However, these models have remained poorly
permissive to ABV infection due to the limited crosstalk between the mouse epithelium/stromal and human
hematopoietic compartments in the skin, their low human myeloid engraftment, and the absence of functional
lymph node structure.
In this proposal, we aim to address these limitations and develop a novel mouse model of ABV
transmission co-engrafted with a functional human immune system (HIS) and autogenic human skin organoids
(HSO). We hypothesize that this model, referred to as SKIN mouse, recapitulates key cutaneous events defining
effective mosquito-mediated ABV transmission to humans. In Aim 1, we will define the ability of SKIN mice to
recapitulate human cutaneous responses to mosquito feeding, using human volunteer data as a benchmark. In
Aim 2, we will demonstrate that SKIN mice support effective ZIKV transmission in a mosquito-feeding-dependent
manner, and we will map the specific human cutaneous responses associated with this process.
This project will generate unique insights into how mosquito feeding remodels human cutaneous
responses to ABV to favor effective viral transmission and systemic dissemination. Our work will also provide an
instrumental platform to the biomedical research community to dissect key cutaneous processes defining the
transmission and pathogenesis of many arthropod-borne diseases relevant to the NIH’s mission, from arboviral
diseases to arthropod-mediated bacterial diseases (e.g., Lyme disease) and autoimmune disorders. By opening
such avenues, this project will prove instrumental for the development and/or evaluation of preventive clinical
strategies against these diseases.

Public health relevance
NARRATIVE Arthropod-borne viruses (ABV), such as Zika virus, cause significant health and economic concerns worldwide, highlighting the urgent need for new preventative and therapeutic interventions against these viruses. ABV are transmitted to humans through the bite of infected arthropods, but how mosquito saliva remodels skin responses to favor ABV transmission is still poorly understood due to the lack of animal models that accurately mimic human cutaneous responses to natural ABV transmission. By developing a novel mouse model that replicates human skin responses to mosquito feeding and supports effective mosquito-mediated ABV transmission, this project will transform our understanding of human skin processes defining the transmission and pathogenesis of arboviral diseases, paving the way toward innovative preventative strategies against these diseases.